Endophenotypes of Persistent Post-Concussive Symptoms in Adolescents: CARE4Kids

PROJECT SUMMARY/ABSTRACT – Overall
The prediction, detection, management and prevention of persistent post-concussive symptoms (PPCS)
represent some of the most important neurological challenges in the science of traumatic brain injury (TBI) today.
For the purposes of this application, PPCS will refer to post-concussive symptoms lasting ≥3 months, consistent
with the National Institute of Neurological Disorders and Stroke Common Data Elements for concussion. We
approach this using the concept of endophenotypes, quantitative behavioral traits characterized by objective
measures using blood-based, imaging or autonomic measures or other techniques. Understanding the
endophenotypes of PPCS will provide opportunities for early identification and potentially for intervention,
treatment and prevention. The overarching goal of this application is to develop a predictive algorithm for
PPCS endophenotypes in early and middle adolescents (EMA) to inform clinical screening, management
and future research. Our specific aims are: Specific Aim 1. In a Development Cohort, develop and characterize
individual objective biomarkers predictive of PPCS by combining biomarkers with symptom clusters and
neuropsychological function. Biomarkers will be examined in 3 Research Cores: Autonomic, Imaging and Blood-
based. Specific Aim 2. To develop and characterize endophenotypes of PPCS in EMA by combining two or
more objective biomarkers with symptom clusters and neuropsychological measures. Specific Aim 3. To
prospectively validate endophenotype biomarkers from Aims 1 and 2 in a broad group of EMA with concussion
(Validation Cohort). Specific Aim 4. To create a clinically useful risk stratification algorithm using validated
biomarkers, in conjunction with symptoms and neurobehavioral function, which will predict the development of
PPCS. The Development Cohort will be recruited from existing concussion and sports medicine clinics at 6
sites within the Four Corners Youth Consortium (4CYC). This cohort will include subjects presenting from 0-12
months after concussion, will likely be enriched in those with PPCS, and has proven feasible for recruitment into
an observational prospective registry. The Validation Cohort will be recruited from the same clinics but also
expanded to primary care clinics/networks and emergency departments (acutely/subacutely) and followed to a
chronic time point. With this broader and more generalizable cohort, the candidate blood-based, imaging and
autonomic biomarkers from the Development Cohort will be tested and validated. It is from these 2nd cohort data
that a predictive algorithm (likely combining clinical and biomarker measures) will be developed.

Public health relevance
PROJECT NARRATIVE – Overall Concussions affect nearly 3 million Americans annually, with up to 30% not recovered 3 months after injury, and the risk for adolescents is even greater. Persistent post-concussive impairments such as migrainous headache, abnormal stress responses and mood dysregulation are common. In this work we will determine the best markers that predict these symptoms in order to provide a firm foundation for future clinical trials to treat these symptoms.